Mechanisms of Circadian Entrainment and Plasticity

PROJECT SUMMARY
A fundamental question in biology and medicine is - how do genes and gene networks give rise to physiology,
function, and behavior? The brain’s endogenous 24-hour timing mechanism, or circadian clock, is uniquely
advantageous for studying the molecular physiology of neural function and the genes-to-behavior problem
because both the neural substrates and gene networks are highly defined, particularly in two molecular genetic
model organisms – mice and fruit flies. The neural networks that time circadian rhythms in physiology and
behavior are located within the suprachiasmatic nuclei (SCN) of the hypothalamus in mammals and in neuron
clusters in the dorsal and lateral Drosophila brain. Circadian clock neurons in mice and flies exhibit self-
sustained circadian rhythms in spontaneous spike frequency driven by networks of clock genes organized in
transcription/translation negative feedback loops (TTFLs) that generate ca. 24-hour rhythms.
While much is known about the genes, neurons, and synapses that are critical for the generation of circadian
rhythms, there are key gaps in our knowledge regarding the mechanisms of synchronization of these internal
clocks to local environmental time - the process of entrainment, and the striking pacemaker plasticity
entrainment induces. Entrainment to different seasonal day lengths (photoperiods), or even a single clock reset
by a light pulse, can enduringly alter the intrinsic waveform, period, and resetting properties of circadian clocks.
The long-term plasticity of circadian clocks in response to entraining light cycles is thought to be critical for
stable alignment to changing seasonal photoperiods, and likely contributes to disorders of desynchrony, SCN
changes in aging, and to discordance between SCN and peripheral tissue clocks.
An overarching interest of my laboratory is to elucidate fundamental cellular and molecular
mechanisms of circadian entrainment and clock plasticity. To this end we have developed novel methods
for direct observation and manipulation of clock entrainment dynamics at the molecular, cellular, and neural
network levels. Our approach, which we call EX vivo CIrcadian Timing and Entrainment (EXCITE), combines
optogenetic manipulation of clock neuron electrical activity with real-time bioluminescence reporting of clock
gene activation and rhythms. In addition, to further understanding of molecular genetic mechanisms of
entrainment we have recently elucidated candidate transcriptomic mechanisms of SCN photoperiod-induced
plasticity, as well as explored the evolution of human clock genes in the form of genomic introgressions from
Neanderthals and Denisovians as adaptions to high latitude seasonal light cycles. We have also extended our
studies of entrainment to the honey bee clock which has a unique molecular structure. Our overall plan for the
next five years is to combine these innovative findings and approaches to address critical gaps in knowledge
regarding clock entrainment and light-induced clock plasticity.

Public health relevance
PROJECT NARRATIVE The brain’s biological clock is composed of a group of nerve cells that generate 24-hour rhythms through the action of clock genes to time the sleep/wake cycle and many other bodily processes. There are many human health conditions that are associated with dysregulation in clock function, including sleep abnormalities, schizophrenia and depression, metabolic syndrome, and age-related circadian disfunction. This research seeks better understanding of how light input that sets the brain clock affects its long-term function and genetics, and will identify biological mechanisms by which mis-alignment of the clock may contribute to disease processes that could be corrected through optogenetic, genetic or photobiological interventions.